Community Outreach and Engagement

COMMUNITY OUTREACH AND ENGAGEMENT - ABSTRACT
The purpose of the Community Outreach and Engagement (COE) component of the UH Cancer Center
(UHCC) is to lead or facilitate activities across UHCC programs and with community stakeholders, and address
cancers of particular priority for our catchment populations. We have selected these priority cancers through
bidirectional community interactions, and targeted them for outreach and health education as well as
innovative population, basic, clinical, and translational research. UHCC’s catchment area includes the
Hawaiian archipelago and a vast expanse inclusive of the US-Affiliated Pacific Islands (USAPI). Hawai‘i, which
has a population of 1.46 million people and has no racial/ethnic majority. Approximately 20-24% of its
population are of Native Hawaiian (NH) ancestry; the United States Affiliated Pacific Islands (USAPI) have an
additional 600,000 residents and vary in economic development across different jurisdictions. These unique
demographics, economic disparities, and geographic expanse inform the strategies through which UHCC
strives to accomplish its mission. UHCC’s exceptional research has long considered our population’s rich racial
and ethnic diversity and investigates the biological, social-behavioral and environmental differences affecting
cancer risk and outcomes while also defining culturally appropriate interventions to reduce the burden from
cancer. We particularly emphasize Native Hawaiians and other Pacific Islanders (NHPIs) who experience
significant cancer disparities compared to other US racial and ethnic groups. Extensive community-facing
programs in cancer prevention and in clinical trials through the NCI-sponsored Minority Underserved
Community Oncology Research Program (MU-NCORP) have been extremely successful in enrolling high
percentages of racial/ethnic minorities to intervention trials. In those parts of the USAPI that have limited
access to oncology care, efforts are focused on cancer prevention. The previous review noted that “the value
added by the COE component is clear and evidenced by the unmatched need for cancer care that challenges
the diverse and remote population the UHCC serves.” In the past five years, the UHCC has strengthened its
COE infrastructure to more robustly engage community partners, further assess its catchment area’s cancer
burden, actively identify community-driven priorities, and effectively communicate community needs to its
research programs. It has also developed new initiatives to disseminate innovative evidence-based
interventions in the community. These efforts at education, outreach, and engagement, plus our involvement in
the State of Hawai‘i Ten-Year Cancer Plan 2030, have had a substantial impact in reducing ethnic disparities,
improving clinical trial participation, and guiding beneficial cancer policy. Our COE-facilitated research has also
influenced changes in lung cancer screening guidelines and diet recommendations nationally. Future plans will
expand COE activities to optimize the benefits of outreach and research among all populations and ultimately
have a profound impact on reducing the cancer burden and disparities in our catchment area and beyond.